Targeting the ANG/TIE2 pathway to treat Alzheimer's disease and related dementias

PROJECT SUMMARY
Clinical trials for Alzheimer’s disease and related dementias (ADRDs) have had only limited success in treating
dementia. Growing evidence suggests that a major contributor to many ADRDs is blood brain barrier (BBB)
compromise and cerebrovascular dysfunction. The overarching aim of this proposal is to test whether BBB
compromise and cerebrovascular dysfunction can be prevented by targeting the Angiopoietin/TIE2 (ANG/TIE2)
pathway. The ANG/TIE2 pathway is a key regulator of BBB integrity. Angiopoietin-1 (ANGPT1) binds the receptor
TEK tyrosine kinase (TIE2), which results in TIE2 phosphorylation (phospho-TIE2, p-TIE2) and activation.
Activated p-TIE2 modulates BBB integrity through increasing tight junction proteins. Conversely, binding of
Angiopoietin-2 (ANGPT2) to TIE2 prevents phosphorylation and activation, resulting in decreased BBB integrity.
Vascular Endothelial Protein Tyrosine Phosphatase (VE-PTP) prevents phosphorylation of TIE2, thus inducing
inflammation-induced vascular permeability. Studies have shown that targeting the ANG/TIE2 pathway improves
vascular health in pulmonary arterial hypertension, microvascular thrombus formation in sepsis, and diabetic
retinopathy. However, no studies have investigated a direct link between the ANG/TIE2 pathway and BBB
integrity in ADRDs. Therefore, we will test our hypothesis that manipulating the ANG/TIE2 pathway will
preserve BBB integrity and cerebrovascular function in ADRDs. We will use the novel wild-derived
WSB.APP/PS1 mouse model, which develops hallmarks of ADRDs including parenchymal plaque deposition,
cerebral amyloid angiopathy, neuroinflammation, neurodegeneration, and cognitive deficits. In Aim 1, we will
test the hypothesis that decreasing ANGPT2 levels will increase p-TIE2, strengthen tight junctions, and
stabilize the BBB—thereby preventing cerebrovascular damage. We will create cohorts of WSB.APP/PS1 and
WSB (no amyloid control) mice heterozygous for Angpt2 (Angpt2+/-), which will age to 4 (plaque onset) and 8
months (overt ADRD phenotypes). At these timepoints, we will assess cognition, cerebrovascular integrity,
amyloid deposition, neurodegeneration, and neuroinflammation using a battery of in vivo and postmortem
assays—including novel spatial recognition, positron emission tomography/computed tomography (PET/CT),
vascular leakage, biochemistry, and immunohistochemistry. In Aim 2, we will test the hypothesis that treating
WSB.APP/PS1 mice with the VE-PTP inhibitor AKB-9778 will also increase p-TIE2 and stabilize BBB function—
thereby reducing ADRD phenotypes. To test this, we will follow a robust preclinical pipeline developed by the
Model Organism Development and Evaluation for Late-onset AD (MODEL-AD) consortium. After determining
the dosing regimen through pharmacokinetic modelling, WSB.APP/PS1 and WSB control mice will be dosed
with AKB-9778 from 4 to 8 months, and phenotypes will be assessed using the same assays described in Aim
1. Collectively, our synergistc genetic and pharmacological approach extensively evaluates the potential for
targeting the ANG/TIE2 pathway to prevent and/or treat ADRDs.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease and related dementias (ADRDs) are the most common forms of dementia yet treatments that prevent or slow cognitive are extremely limited. Blood vessel decline in the brain has emerged as key component of many ADRDs making preserving blood vessel health a viable therapeutic option. In this proposal, we will use a combination of genetic and pharmacological approaches in mice to test the potential for targeting the Angiopoietin/TIE2 pathway – a biological process known to regulate blood vessel health – to treat ADRDs.